Development of Real-time MR imaging and Visualization System to Improve MR-guided Prostate Biopsy

Abstract
MR-­guided in-­gantry prostate biopsy is a state-­of-­the-­art technique that has considerable advantages over
other prostate biopsy methods, including increased lesion targeting accuracy and fewer side effects with
shorter recovery times. However, performing the procedure is difficult and time-­consuming due to a variety of
factors. High-­resolution T2-­weighted images used to guide the needle have long acquisition times resulting in
slow needle adjustments. Furthermore, guidance in MR-­guided biopsy relies on support software that is prone
to error due to different geometry between biopsy planning and guidance images. Manual visual guidance,
often done to compensate for errors with support software, can be inaccurate due to slow pace of visual
feedback, leading to repeat guidance image scans and thus longer procedure times. Hence, a new way to
approach imaging and visualization of data in MR-­guided prostate biopsy is a necessary step to reduce
procedure complexity and duration and improve patient accessibility to this diagnostic technique.
A guidance image in MR-­guided biopsy requires 40-­60 seconds to acquire. Progress made in Case
Western Reserve University (CWRU) MRI research group has enabled fast imaging that can accelerate image
collection by more than a hundred-­fold. Fast MR method development will build upon currently utilized fast spin
echo imaging methodology and integrate advancements in non-­traditional data sampling techniques and
parallel imaging to enable collection of guidance images in a few seconds. Rapidly acquired guidance images
will provide superior temporal resolution to current technique with sufficient image quality to enable accurate
targeting of lesions in MR-­guided prostate biopsy.
While fast image acquisition improves the temporal resolution of visual feedback in MR-­guided prostate
biopsy, procedure complexity arises from imaging in different imaging planes between planning and guidance
images and targeting lesions that have insufficient contrast in these images. Non-­rigid image registration will
enable visual fusion between not only planning and guidance images, but also higher quality pre-­biopsy
diagnostic images which provide better tissue contrast for lesion targeting. Augmented reality holographic
rendering will be implemented in conjunction with image registration to visualize the complex 3D spatial
relationships between the different image datasets. The combination of image registration and holographic
visualization will provide more informative spatial information during MR-­guided prostate biopsy, allowing
radiologists to better utilize their trained intuition and thus reducing procedure complexity and reliance on
support software for lesion targeting.
Together, fast MR imaging and augmented reality visualization techniques proposed herein will reduce
procedure time and difficulty, thereby helping increase adoption and patient accessibility to MR-­guided prostate
biopsy.

Public health relevance
Project Narrative Current transrectal ultrasound guided prostate biopsy requires systematic sampling of the prostate due to inability to accurately identify foci of disease, resulting in false negatives and repeat biopsies that increase patient anxiety and risk of post- procedure complications. In- gantry magnetic resonance guided prostate biopsy has demonstrated greater value to prostate cancer diagnosis by increasing biopsy accuracy, and thus reducing the need for repeat biopsies; however, the technique is time- consuming as well as difficult to teach and perform which has prevented widespread adoption. We propose novel fast MR imaging and augmented reality visualization techniques that will make MR- guided biopsy faster and more intuitive to perform.